Alcohol-Involved Sexual Assault among Women: Disentangling Mechanisms of Risk Across the Lifespan

The purpose of this Mentored Research Scientist Development Award (K01) is to help the candidate, Dr. Jessie Ford, become an independent researcher focused on identifying modifiable multi-level factors that can explain and address the high rates of alcohol-involved sexual assault among women across the lifespan in the US. Research shows large differences in both alcohol-facilitated sexual assault and hazardous drinking across groups of women with different patterns of attraction and relationship histories. Thus, it is imperative to study how alcohol interacts with other social forces to create risk in order to prevent harm. To examine this topic, the candidate requires training in each of the following areas: 1) risk and protective factors for hazardous drinking; (2) lifespan research methods for alcohol use and sexual assault; (3) conceptualizing and measuring multi-level determinants; and (4) mixed methods. Training will occur alongside a career development plan that includes specific seminars, workshops, coursework, conferences, hands-on practica, and tailored mentoring with a mentorship team comprised of experts in alcohol use, lifespan and longitudinal research methods, social factors, risk taking, sexual assault, mixed methods, and advanced statistical methods. The candidate will use this new training data to build a novel conceptual model describing disproportionate risk for alcohol-involved sexual assault, with attention to the multi-level effects of individual, interpersonal, and structural factors across the lifespan. To test this model, I will utilize a multi-method design across 3 studies that draw on the methodological strengths of longitudinal cohort, multi-site cross-sectional, and mixed-methods data. These datasets include: 1) the Chicago Health and Life Experiences of Women Study (CHLEW), 21-year study of 181 women across time (ages 18-84); 2) the Online College Social Life Survey (OCSLS), a multi-site study of 638 women (ages 18-25) at 22 universities; and 3) my own primary data: The Women, Alcohol and Sexual Health (WASH) 2-wave survey of 800 women in a US general population sample. Further, the candidate will conduct 30 in-depth interviews with women who have experienced alcohol-involved sexual assault recruited from the WASH sample, integrating survey data with qualitative data to further elucidate mechanisms. This research will provide critical formative data that will be used to develop a NIAAA R01 proposal that will allow Dr. Ford to create a prospective dataset to identify multi-level etiologic pathways (all in 1 dataset) that affect alcohol use and sexual health. The new skills acquired through this K01 will help the candidate achieve her career goal of becoming an independent investigator who conducts transformative, cross-disciplinary work that advances research on determinants of alcohol use and adverse sexual health outcomes.

Public health relevance
Studies show large differences in alcohol-involved sexual assault across groups of women with different patterns of attraction and relationship histories. Research into the underlying factors that can explain these patterns constitutes a critical area for public health. The proposed research will use multiple methods and datasets to identify modifiable determinants of alcohol-involved sexual assault across the lifespan that can be used to inform public health interventions aimed at reducing these assaults in affected populations. Modified Specific RPPR- Sections B1- B6 B.1. What are the major goals of the project? Specific aims: Research shows large differences in sexual assault6,23,29 and hazardous drinking,23-25,45-48 across groups of women with different patterns of attraction and relationship histories.6,12,16-22 Yet, the mechanisms that lead to this dual risk are poorly understood. To advance this literature, research could benefit from additional methodological and conceptual innovation. Specifically, most studies are cross-sectional and focus on a single level of analysis,29,42 precluding our ability to examine women’s lifespan trajectories and risk across multiple levels (i.e., individual, interpersonal, contextual) at different developmental periods. This study brings an innovative approach using longitudinal, multi-level data to expand our understanding of the social production of alcohol-involved sexual assault for women. In the proposed training, my over-arching goal is to develop skills in 4 areas relevant to the study of sexual assault and drinking within women: (1) risk and protective factors for hazardous drinking; (2) lifespan research methods for alcohol use and sexual assault; (3) conceptualizing and measuring multi-level determinants; and (4) mixed methods. This training will provide skills needed to conduct methodologically sophisticated and transformative research focused on understanding the factors that contribute to the risk for alcohol-involved sexual assault within women across the lifespan. Addressing sexual assault as a consequence of drinking is described as an important priority at NIAAA. My research will use quantitative and qualitative data to build a framework exploring which women are most at risk for alcohol-involved sexual assault, with attention to the multi-level effects of individual, interpersonal, and contextual factors across the lifespan. I will evaluate an epidemiologic model positing that: (1) some women may be exposed to discrimination and mistreatment based on histories of attraction and relationships; and (2) over time, contextual conditions combine with individual and interpersonal factors to increase the risk of alcohol-involved sexual assault. To test this model, I will utilize a multi-method design across 3 studies that draw on the methodological strengths of longitudinal cohort, multi-site cross-sectional, and mixed-methods data. These interconnected studies build on each other as follows. In Study 1, I use data from the Chicago Health and Life Experiences of Women Study (CHLEW), a landmark 21-year study of 181 women (ages 18-84), to examine individual and interpersonal risk and protective factors for hazardous drinking and sexual assault. While CHLEW has the benefits of a lifespan design with strong measures of how risk unfolds from adolescence through later adulthood, the context is less variant, because all women were recruited in a single site. Thus, in Study 2, I incorporate geographic variation through the use of the Online College Social Life Survey (OCSLS), a multi-site study of 638 women (ages 18-25) at 22 universities. OCSLS has rich measurement of interpersonal factors and institutional micro-contexts; yet, the data are cross-sectional with detailed measures of risk only during young adulthood. In Study 3, I create a 2-wave survey—the Women, Alcohol and Sexual Health (WASH) Study—of 800 women in a US general population sample that examines multi-level risk factors at specific time periods (e.g., young adulthood, midlife, later adulthood). This data collection, in year 3 of the K01, will incorporate significant predictors from OCSLS and CHLEW. Study 3 also includes in-depth interviews in order to further elucidate risk pathways and mechanisms. These studies will test the following aims: Aim 1: To identify individual and interpersonal risk factors across the lifespan for alcohol-involved sexual assault (CHLEW data). (Hypothesis 1): Individual (e.g., identity-development milestones; history of abuse) and interpersonal (e.g., relationship histories) risk factors at specific developmental periods will independently and jointly predict a heightened risk for alcohol-involved sexual assault for some women.27,37 Aim 2: To evaluate interpersonal and institutional contexts during a key developmental period (age 18-25) as risk factors for alcohol-involved sexual assault (OCSLS data). (Hypothesis 2): Interpersonal risk factors and institutional micro-contexts (e.g., Greek life) will independently and jointly predict heightened risk for alcohol-involved sexual assault for some college-attending women.13 Aim 3: To use mixed methods to evaluate multi-level determinants for alcohol-involved sexual assault at different developmental periods (WASH data). (Hypothesis 3A): Greater exposure to multi-level risk factors (Figure 1) at certain points of development will independently and jointly predict heightened risk for alcohol-involved sexual assault and will explain which women are more likely to experience alcohol-involved sexual assault.54,55 (Hypothesis 3B) Qualitative interviews with 30 women who have experienced alcohol-involved sexual assault (recruited from my 2-wave survey: WASH) will help me better understand how the multi-level factors most predictive of outcomes in Studies 1-3 operate to create risk for alcohol-involved sexual assault. Collectively, these studies will provide necessary pilot data for the development of an eventual R01 proposal that will create a data structure to study multi-level determinants of alcohol use and sexual health prospectively allowing for comprehensive triangulation in one dataset. To accomplish these aims, I am doing this K01 training under a highly productive team of mentors with expertise in alcohol use, multi-level determinants, and sexual violence. This research will significantly contribute to addressing sexual assault as a consequence of drinking, which is an important priority at NIAAA. B.2. What was accomplished under these goals? Over the past year, I focused my efforts on the following tasks (see below). This K01 was terminated in March 2025 so I was not able to conduct the survey planned for aim 3. Continued to conduct data analysis. Throughout the year, I conducted further quantitative analyses as part of my K01 specific research using CHLEW and OCSLS data. Based on these findings, I presented my work at 2 conferences with a focus on alcohol use and sexual risk: 1) the Association of Behavioral and Cognitive Therapies (ABCT) and 2) the World Association of Sexual Health (WAS). In the past year, these analyses produced 1 published paper; 1 in draft; and 1 revise and resubmit. These papers would have guided my primary data collection that was set to begin in April of Year 4, and for future R01 preparation. In terms of my K01 research aims, in year 4 of my K01 (July 2024-July 2025), I made progress on the following two aims: Aim 1: To identify individual and interpersonal risk factors across the lifespan for alcohol-involved sexual assault within women (CHLEW data). To work toward this aim in Year 4, I continued analysis of CHLEW data with attention to risk and protective factors for alcohol use and sexual assault. I published one manuscript focused on how novel mediators (stigma, identity development, discrimination) explain higher rates of sexual assault among women with different patterns of attraction and relationship histories. This manuscript was published in the International Journal of Sexual Health. We have a revise and resubmit on a separate manuscript examining alcohol use, age, sexual identity and past victimization as predictors of prospective sexual assault across time (R&R) at the Psychology of Violence. Aim 2: To evaluate interpersonal and institutional contexts during a key developmental period (age 18-25) as risk factors for alcohol-involved sexual assault (OCSLS data). During year 4 of the K01 I continued analysis with OCSLS data. I submitted a paper using an mediation analysis in relation to alcohol-involved sexual assault among women (described below) with a focus on substance use and sensation seeking. This paper is under review at Violence against Women. Aim 3: To use mixed methods to evaluate multi-level determinants for alcohol-involved sexual assault at different developmental periods (WASH data). In year 4 of the K01, building from findings in the above aims as well as the literature base, I created a baseline national survey of women (WASH) to be fielded in spring 2025. This survey would have included 800-1000 women followed in-depth interviews with 30 women who experienced alcohol involved sexual assult. I worked with mentors and the (IPSOS) survey company to program the survey but this K01 grant was terminated before we could field it. Published, submitted and prepared manuscripts. In year 4 of my K01, my research has culminated in 6 published papers (5 first-author; 1 second-author); 2 in press; 8 papers under review (5 first author), and an additional 6 papers in preparation. One published paper (first authored) in the International Journal of Sexual Health - examines how women’s different patterns of attraction and relationship histories leave them more vulnerable to sexual assault. The second published paper in Stigma and Health (first-authored) is a conceptual paper that focuses on how we might better conceptualize the way we think about stigma for people with an emphasis on qualitative lived accounts. The third published paper (first-authored by myself) uses ethnographic work, field observation, in depth interviews, and survey data to explore the sexual health, drug/alcohol use, and overall health of men who have sex with men in Mexico. We find that in Oaxaca, Mexico there is a level of respect and integration within families and broader society that supports health. Our findings suggest it may be less stigmatizing to be sexually diverse in Oaxaca, Mexico than in many parts of the world despite there being a range of social tolerance and discrimination. We discuss implications for HIV risk, drug/alcohol use and overall health. The fourth published paper (second authored) published in PLOS Global Public Health reviews key literature on sexual pleasure in HIV interventions. The research shows how positive framing can extend and strengthen existing HIV intervention work. The fifth published paper in the Journal of Family Theory & Review (first-authored) uses sociological theory and the US legal system to examine instances of sexual violence, forced marriage and reproductive justice in the current landscape of research on self determination around these things. Findings show that certain patterns of attraction and relationship histories heighten the risk of experiencing all of these outcomes while also increasing the risk of being forced into unwanted social arrangements. Maintained a system for tracking new paper ideas. I continued to use an excel sheet as well as a concept sheet that I developed to propose new paper ideas for my K01 datasets. I have shared concept sheets with my mentors and collaborators who have approved them; these papers are in various stages of preparation. B.4. What opportunities for training and professional development has the project provided Rigorous mentoring for my career development. My K01 training includes four areas with four experts: (A) risk and protective factors for hazardous drinking (Dr. Tonda Hughes); (B) lifespan research methods for alcohol use and sexual assault (Dr. Kerry Keys); (C) conceptualizing and measuring multi-level determinants (Dr. Mark Hatzenbuehler); and (D) mixed methods (Dr. Jennifer Hirsch). I made progress in all 4 areas during year 4 of the K01. A) Risk and protective factors for hazardous drinking: In year 4 of the K01, I continued to train with Dr. Hughes, an expert in this area. I joined a weekly 1.5 hour research meeting to further analyses with CHLEW and a couples supplement. We currently have 6 collaborative papers in draft from this work. Dr. Hughes and I meet as needed (usually monthly). Under her guidance, I’ve continued to read and discuss literature on the measurement, categorization, and analysis of alcohol use; I reviewed articles for alcohol journals I created and submitted a research proposal for a new CHLEW (first author) paper and shared preliminary findings with Dr. Hughes. Additionally, I attended the bi-weekly fellow group run by Dr. Hughes which includes research presentations by early career scholars and discussion. I also attended separate lab meetings for the CHLEW research team. Using these new skills, I co-authored the published paper described above and submitted the first-author paper described above. B) Lifespan research methods for alcohol use and sexual assault: To advance my understanding of training aim B, I trained with Dr. Jennifer Hirsch and Dr. Kerry Keyes who both have expertise in this area. Building from my independent study in with Dr. Keyes, we’ve stayed in touch with reading, seminars, upcoming trainings and papers. Dr. Keyes and Dr. Hirsch are both on my first R01 which was submitted in June 2025 (focused on a group of men who have sex with men in Mexico). Dr. Keyes has had me review articles for the alcohol journal that she runs. Discussion with Dr. Keyes enabled my progress on the analyses that led to my second-authored CHLEW paper (R&R at Psychology of Violence) that examines age as a specific and complex risk factor for sexual assault. Separately, I met with Dr. Hirsch every week during the year in her role as my Primary Co-Mentor to ensure I was making progress toward my broader K01 goals. Working with Dr. Hirsch, I published a review paper (on forced sex, marriage and reproduction) and have also continued analysis of the OCSLS data focused interpersonal and institutional contexts for alcohol-involved sexual assault in college. This involved reviewing theoretical and empirical literature with a focus on sexual citizenship, institutional rootedness, and typologies of women. In fall 2024, I taught the class “Theories and Perspectives on Sexuality and Health” (a class formerly taught by Dr. Hirsch; she provided mentorship as I designed and taught the course). C) Measuring multi-level determinants: To progress in my ability to measure and conceptualize multi-level determinants I worked with Dr. Hatzenbuehler to analyze and conceptualize contextual measures related to alcohol and substance use. I attended Dr. Hatzenbuehler’s lab to discuss ways to improve existing measures of stigma. I have one qualitative paper with Dr. Dodge and Dr. Hatzenbuehler focused on ways that structural and contextual stigma could be better conceptualized (this is in press). D) Mixed Methods: To gain training in mixed-methods approaches that combine survey data with in-depth qualitative interviews, I published my work with Dr. Hatzenbuehler on a mixed methods study (examining structural stigma related to sexual orientation) using a nationally representative study of 500 men with 60 in-depth interviews. The paper based on this work (published in Stigma and Health) uses mixed methods to expand current understandings of structural stigma. Dr. Hatzenbuehler and I met monthly over the past year. Career development for predoctoral students. This K01 research has provided predoctoral research training to four students: 3 PhD students (Aarushi Shah, Ruth Shefner and Gloria Fortuna) and 2 MPH students (Amanda Sheehan and Jessica Weissman). Ms. Shah and Fortuna have worked with me on mixed methods data analysis and Ms. Fortuna has done work with the OCSLS data; Ms. Shefner has worked on quantitative analyses in CHLEW and OCSLS. Ms. Sheehan has worked on the CHLEW research and Ms. Weissman on the WASH 2025 survey that was not done. Attended conferences. In Year 4, I attended two conferences (ABCT and WAS). I’ll also be attending one in August (American Sociological Association) with my personal funding. I presented on my K01 work at each conference. Attended seminars and workshops. Throughout Year 4, I attended lecture and seminar series of the Columbia Population Research Center; the Department of Sociomedical Science’s Gender Sexuality and Health Seminar; Lectures at Columbia’s Center for the Study of Social Inequalities and Health; the Columbia Seminar in Substance Use Epidemiology and the Harvard University-Alcohol and Substance Abuse (Online Learning Series). I presented my research at the Gender, Sexuality, and Health seminar for graduate students in Columbia’s Department of Sociomedical Sciences and I also brought in a speaker who spoke about HIV approaches in the UK. Group meetings with junior faculty. I also attended group meetings with junior faculty throughout the academic year. These meetings provided me with information, guidance and encouragement, and a place to address professional concerns or problems. The meetings also gave me an opportunity to experience mutual support and share experiences and strategies for coping with the challenges I faced this year. Individual meeting with department chair. Finally, during Year 4 of the K01, I had a series of individual one-on-one mentoring meetings with my Department Chair: Dr. Sikkema. This was especially valuable to me as a junior faculty member because it provided individualized attention. Dr. Sikkema and I used this time to discuss my K01 analyses, my overall research agenda, my specific aims for my June 2025 R01 submission and generally made sure I was on track for meeting goals for the year. B.5. How have the results been disseminated to communities of interest? I have shared my published papers with the Columbia press team, with CDC colleagues and as part of the Mailman School of Public Health weekly updates. B.6. What do you plan to do during the next reporting period to accomplish the goals? Activities for Year 5 of the award will include the following: Collecting and validating measures. In Year 5, I will identify and collect the measures for some of my key independent variables related to patterns of disparity and stigma—measured via a composite index of laws, policies, and social attitudes, which I will link into the primary data collected in year 5. Using a variety of publicly available data and data from academic colleagues, these indicators of patterns of disparity and stigma at the state-level will a series of objectively-coded components: state-level policies related to disparity and sexual orientation. Once obtained, I will conduct a factor analysis on these items, in hopes that a single factor will emerge based on disparity and stigma. I will also collect and include state-level covariates including: measures of disparity, well-being, mental health, unemployment, average age and other population demographics. Finalize Wave 1 of the WASH. Year 5 of the study will involve finalizing and fielding, My primary research study-WASH. This survey includes a variety of validated items designed to measure behaviors and attitudes longitudinally. I have already begun been working with IPSOS on multiple iterations of the survey to reduce the number of items to fit within the allotted time period (30 minutes) and to prepare the survey for programming (e.g., modifying the presentation of certain items for use with smartphones and translating the survey into Spanish), piloting, and data collection. Conduct longitudinal analyses. I will continue conducting analyses of the Waves 3-5 of the CHLEW data during Year 5 of the award in preparation for ongoing and future manuscripts. These analyses will focus on further evaluating Aim 1 of the project. Conduct multi-level analyses. I will continue conducting multi-level analyses of both the CHLEW and OCSLS data during Year 5 of the award in preparation for ongoing and future manuscripts. These analyses will focus on evaluating Aims 1-3 of the project. Convene team meetings. With my mentors, I will continue to have regular meetings, biweekly meetings my primary mentor(s), and monthly meetings other mentors and collaborators. Engage in training and professional development for myself and other predoctoral and postdoctoral advisees. I will continue to gain training and mentorship. I will also provide professional development opportunities for predoctoral and postdoctoral students involved in the project. Apply for an R01. Based on the findings from my K01, I will apply for an R01 to continue this important research with application both to women and also to the general population more broadly.